Novel Regulation of Oncogenic NRAS Signaling in Myeloid Malignancies

Summary
Hematopoietic stem and progenitor cells (HSPCs) are regulated by a balanced signaling network, which is critical
for HSPC homeostasis and prevention of malignant transformation. We previously showed that protein
ubiquitination by CBL family E3 ubiquitin ligases controls JAK2 stability and activity that is important for curbing
HSPC expansion and myeloid malignancies. Here we identified a novel signaling axis, where CBL/JAK2
upregulates RAB27B to enhance NRAS GTPase activity and ERK signaling. Importantly, aberrant activation of
this pathway is critical for leukemia cell growth conferred by CBL and RAS mutations. Intracellular signaling can
be dynamically modulated by post-translational modifications (PTMs) that regulate the temporal and spatial
distribution of signaling proteins. RAB27B, a Rab GTPase that is resident in the Golgi and endosome
membranes, regulates intracellular vesicle trafficking, docking, and fusion with plasma membrane (PM). Rab27b
knockout mice display normal steady-state hematopoiesis. Strikingly, we found that Rab27b deficiency in primary
HSPCs abrogates mutant but not wildtype NRAS-mediated signaling and cell growth. Mechanistically, we
demonstrated that RAB27B regulates NRAS palmitoylation, GTPase activity, stability, and subsequent c-
RAF/MEK/ERK activation. RAS proteins propagate signals only when associated with cellular membranes as a
consequence of various PTMs that impact their trafficking between endomembranes and the PM. Therefore, a
precise understanding of RAS’ interaction with membranes and trafficking is essential to understand RAS action
and to intervene in RAS-driven cancers. The discovery of RAB27B as a novel regulator of RAS palmitoylation,
a lipid modification for membrane anchors, propelled us to further define the molecular basis underlying the
regulation of RAS/ERK signaling by CBL/JAK2/RAB27B and explore its functional significance in malignant
HSPCs. In aim 1, we will investigate if Rab27b deficiency mitigates chronic myelomonocytic leukemia (CMML)
development and malignant HSPC expansion induced by mutant Nras or Cbl deficient mice. More importantly
we will study if Rab27b deficiency dampens NRAS signaling, stability, lipid modification and subcellular
localization. In aim 2, we will use live-cell imaging and biochemical assays as well as genetic approaches, to
dissect the dynamic regulation of NRAS trafficking, palmitoylation, and compartmentalized signaling by RAB27B.
In aim 3, we will investigate the role of mutant CBL/JAK2 in regulating RAB27B level and explore the therapeutic
potential of targeting RAB27B in primary HSPCs from human myeloid malignancies. RAS pathway mutations
including NRAS and CBL define the proliferative CMML (pCMML) phenotype that is aggressive, predisposed to
AML transformation and associated with dismal outcomes. This work uncovers novel RAB27B-mediated
compartmentalized signaling dynamics that is crucial to key signaling proteins, and serves the basis for future
therapeutic strategies for molecular targeting.

Public health relevance
Narrative A precise understanding of RAS’ interaction with membranes and trafficking is essential to understand RAS action and to intervene in RAS-driven leukemias. This work uncovers RAB27B GTPase that is crucial to oncogenic NRAS lipid modification, trafficking, signaling and cell growth. It serves the basis for future therapeutic strategies for molecular targeting of various myeloid malignancies.